Administrative Core

The Lung Inflammatory Disease Program of Excellence in Glycosciences (LID-PEG) has Projects and Cores at three institutions and a breadth of capabilities ranging from chemistry to preclinical therapeutic models. With this diversity, communications will be a key to LID-PEG progress and success. A major role in effective communication will be provided by Core A, the Administrative Core. Core A will take responsibility for inter-program communications both through web-based video conferencing and face-to-face meetings. The Core will coordinate and oversee the regular video-conference meetings of the Executive Committee, organize the annual Program Group Meeting (which will rotate among the three sites), organize meetings of the LID-PEG with its Internal and External advisory boards and support LID-PEG participation in the annual Investigator's meeting in Bethesda. In addition to travel planning and reimbursement for LID-PEG meeting participants. Core A will coordinate communications with NHLBI and the Administrative Center, manage budgets and fulfill NIH reporting requirements.

Public health relevance
RELEVANCE (See instructions): This Program brings together scientists from across the country to combine diverse expertise in glycosciences with the goal of discovering new therapies for asthma, COPD and other lung and cardiovascular inflammatory diseases. Effective communication is essential to this goal, and Core A will take the lead in ensuring efficient communications among LID-PEG members.